Identifying enhancers with human-specific developmental functions

DESCRIPTION (provided by applicant): As a species, we are distinguished from other primates by our capacity for language, our ability to walk upright, and our talent for inventing and using sophisticated tools. These traits originated in physical adaptations, such as increased brain size and changes in the morphology of the limbs, which required changes in development. Although it has long been thought that changes in gene regulation drove the evolution of uniquely human traits, in vivo evidence for human-specific developmental regulatory functions remains elusive. Moreover, despite intensive efforts to annotate functional elements in the genome, such as the ENCODE project, there is no parallel effort to annotate uniquely human cis-regulatory functions. The goal of this study is to identify and characterize developmental enhancers with human-specific functions in vivo and examine their role in human evolution. The aims of our proposal are based on extensive preliminary data. We have developed a novel computational approach to identify noncoding, potentially regulatory sequences that are highly conserved across vertebrate species, but that changed substantially during human evolution. Using a mouse transgenic enhancer assay, we have identified eight of these human-accelerated conserved noncoding sequences (HACNSs) that function as enhancers during development. Of particular relevance for the aims of this proposal, we have also shown that the most rapidly evolving element in our dataset, HACNS1, is a developmental enhancer that has gained a robust limb expression domain relative to the orthologous elements from chimpanzee and rhesus macaque. This domain includes the presumptive anterior wrist and proximal thumb. Here we will build on these previous studies to generate more sophisticated maps of human-specific sequence acceleration in noncoding elements, including transcription factor binding site data and ChIP-seq data generated by genome-wide efforts to annotate regulatory function. We will use these data in conjunction with computational and experimental filters, such as extreme evolutionary constraint and recruitment of p300, to predict enhancers and mouse transgenic technologies to identify and characterize enhancers with human-specific activities. We will use synthetic enhancers and biochemical approaches to determine how human-specific sequence change alters enhancer function. Finally, we will use a reverse genetic strategy to study the evolutionary relevance of the human-specific functional change in HACNS1, by using gene targeting to replace the mouse ortholog of HACNS1 with the human enhancer and evaluating the effect of this genetic change on mouse development. The results from these studies will complement and extend current efforts to functionally annotate the human genome and will begin to reveal the precise molecular evolutionary events that produced modern humans.

Public health relevance
PUBLIC HEALTH RELEVANCE: Understanding the genetic basis of human morphology and development is central to the public health mission of the NIH. Beyond the fundamental question of human origins, studying human evolutionary history is directly relevant to human health, as many common human diseases may in part be due to the effects of sequence changes that were advantageous early in our evolution but are now harmful. Evidence for this hypothesis stems from human and chimpanzee comparisons: many prevalent human diseases with a genetic component, including skin cancers, heart disease, malaria infection, Alzheimer disease, multiple sclerosis and major psychoses, appear to be uncommon, different or absent in chimpanzees. Our research may thus shed light on the genetic and evolutionary basis of diseases that are unique to our species. Understanding the genetic basis of human morphology and development is central to the public health mission of the NIH. Beyond the fundamental question of human origins, studying human evolutionary history is directly relevant to human health, as many common human diseases may in part be due to the effects of sequence changes that were advantageous early in our evolution but are now harmful. Evidence for this hypothesis stems from human and chimpanzee comparisons: many prevalent human diseases with a genetic component, including skin cancers, heart disease, malaria infection, Alzheimer disease, multiple sclerosis and major psychoses, appear to be uncommon, different or absent in chimpanzees. Our research may thus shed light on the genetic and evolutionary basis of diseases that are unique to our species. __SpecificAimsTextDelimiter__ A. Specific Aims The evolution of physical differences between humans and other primates required genome sequence changes that altered the molecular machinery of development. Although it has long been thought that changes in gene regulation drove the evolution of uniquely human traits, in vivo evidence for human-specific developmental regulatory functions remains elusive. The goal of this research proposal is to identify and characterize developmental enhancers with human-specific functions in vivo and examine their role in human biology and evolution. In preliminary studies, we have developed a novel computational approach to identify 992 noncoding sequences that are highly conserved across vertebrate species, but have rapidly evolved on the human lineage. Using a mouse transgenic enhancer assay, we have identified nine of these "human-accelerated" conserved noncoding sequences (HACNSs) that function as enhancers during development. Of particular relevance for the aims of this proposal, we have also shown that the most rapidly evolving element in our dataset, HACNS1, is a developmental enhancer that shows greatly increased activity, including the gain of a robust limb expression domain, relative to the orthologous elements from chimpanzee and rhesus macaque. In this proposal, we will employ these computational and experimental approaches across the genome to identify and characterize additional developmental enhancers with human-specific expression patterns. We will also introduce HACNS1 into the mouse genome by homologous recombination to model its phenotypic impact during development. The results from these studies will complement and extend current efforts to functionally annotate the human genome, and will begin to reveal the precise molecular evolutionary events that produced modern humans. The aims of this proposal are to: I. Identify developmental enhancers showing evidence of positive selection in humans. The goals of this aim are to further identify and annotate conserved noncoding sequences (CNSs) that show a molecular signature of adaptive evolution in humans, to prioritize HACNSs for experimental analysis, and to determine which function as developmental enhancers using a mouse transient transgenic assay. A. Comprehensive annotation of human-specific evolutionary acceleration in CNSs. Previous efforts to identify noncoding sequences rapidly evolving in humans, although productive, have for the most part only considered point substitutions and been limited to measures of evolutionary conservation based on a small number of species. We will improve on these studies in three ways: 1. We will develop and apply statistical methods to measure human-specific evolutionary acceleration in CNSs identified in whole genome alignments of 44 vertebrate species. This will facilitate analysis of positive selection in CNSs conserved at different phylogenetic distances from human, including CNSs only present in primates. We will take advantage of the Neanderthal genome sequence, which will be released in late 2009, to identify HACNSs unique to modern humans. We will also incorporate insertions and deletions in our analysis. 2. We will estimate the potential functional consequences of selection by determining how human- specific sequence changes in HACNSs contribute to the gain and loss of predicted binding sites for known developmental transcription factors (TFs). To this end we will exploit a recently generated dataset of in vitro comprehensive binding-site information for >100 mammalian TFs, as well as genome-wide ChIP data from ENCODE and other sources. 3. We will identify genomic regions with statistically significant clustering of HACNSs. Such clusters are likely to reveal developmental genes with profound human-specific expression changes arising from evolutionary modification of multiple cis-regulatory elements. B. Enhancer identification. We will use a mouse transgenic enhancer assay to test selected HACNSs for their ability to drive spatiotemporal expression of a lacZ reporter gene in mouse embryos at E11.5 or E14.5. We will prioritize HACNSs for experimental analysis using several criteria: 1. Extreme levels of nonhuman sequence conservation coupled with extreme human-specific sequence acceleration. 2. Evidence the HACNS recruits the enhancer-associated protein p300, based on a published dataset of p300 binding sites in E11.5 mouse limb and brain. Binding of p300 is highly predictive of enhancer activity. 3. Clustering of HACNSs near genes with neurodevelopmental functions. II. Identify and characterize developmental enhancers with human-specific activities. The goal of this aim is to identify developmental enhancers that display human-specific enhancer activity in vivo, and to identify the molecular changes responsible. A. To identify enhancers with human-specific spatial or temporal expression patterns in major developmental domains such as limb and brain, we will establish stable transgenic reporter lines for a subset of HACNS with enhancer activity, as well as for the corresponding chimpanzee elements, and examine embryonic expression at daily intervals from E9.5 to E14.5. This approach will allow us to determine the dynamics of human-specific enhancer activity throughout mid- to late development. B. We will determine the molecular basis of expression changes identified in A. by in vivo analysis of chimeric enhancers, in which human-specific sequence changes are introduced into the chimpanzee enhancer sequence, or "reverted" in the human sequence to the ancestral state. C. We will examine differences in binding of candidate trans-factors to HACNSs using standard methods, including gel shift and supershift assays.. We will also develop methods to identify TFs that bind to enhancers by affinity purification from mouse embryo tissue lysates using concatemers of HACNS enhancer sequences followed by mass spectrometry. These experiments will provide insight into how sequence changes rewrite the cis-regulatory vocabulary and grammar in these elements to generate human-specific functions. III. Reverse genetic analysis of HACNS1 by gene targeting in the mouse: reconstructing the evolution of human development in vivo. The goal of this aim is to develop and apply a reverse genetic in vivo approach to evaluate the phenotypic effect of human-specific functional change in developmental enhancers, using HACNS1 as the test case. A. HACNS1 may have influenced the evolution of human specific limb development by altering the expression of nearby genes. These include AGAP1 and the essential developmental transcription factor GBX2. We will generate transgenic mice that express an AGAP1 or GBX2 cDNA under the control of the HACNS1 enhancer or the chimpanzee ortholog. B. We will use homologous recombination to precisely replace the orthologous mouse enhancer with HACNS1. To differentiate primate-specific from human-specific effects, we will also generate mice in which the mouse enhancer is replaced with the chimpanzee ortholog. To determine the ancestral function of the HACNS1 enhancer, we will generate a deletion line in which the mouse ortholog has been removed. C. Mouse lines generated in A and B. will be phenotyped as follows: 1. Embryos will be collected and examined at 1-day intervals from E9.5 to E16.5. We will also examine the spatiotemporal expression of Gbx2, Agap1 and genes critical for limb development by in situ hybridization. 2. Postnatal mice from each line will be subjected to comprehensive phenotyping in the Yale Mouse Phenotyping Clinic established by Dr. Tian Xu, including morphology studies using micro CT, assessment of locomotive functions, behavioral analyses and metabolic assays. 3. We will also determine how gain of function in HACNS1 impacts global gene expression and regulation by whole transcriptome sequencing of the developing limb at selected time points in wild type and HACNS1 targeted replacement mice. D. Data release. Mouse lines generated in this project will be made publicly available in accord with NIH policy. HACNSs annotations, substitution maps and enhancer expression data will be deposited in public genome databases (UCSC Genome Browser, Vista Enhancer Browser, Ensembl) and will also be available on our lab website. All embryos will be preserved and made available for annotation by outside investigators.